2025 Angiogenesis Gordon Research Conference and Gordon Research Seminar

The 2025 Gordon Research Conference (GRC), “Angiogenesis and Social Interactions with Neighboring Cells and Tissues in Health and Disease”, and the accompanying Gordon Research Seminar (GRS) “Deciphering Intercellular Dialogues in Angiogenic Microenvironments” address the underlying hypothesis that by being deeply embedded within the context of tissues and organs, angiogenesis relies on intricate crosstalk with neighboring cells. Interactions with various cell types in different tissues influence blood vessel patterning and function. Conversely, ECs secrete organotypic angiocrine factors that control and maintain tissue homeostasis. Understanding these interactions is important for tissue regeneration and for treating diseases involving aberrant vascularization.
The conference aims to bridge knowledge and communication gaps between researchers at all levels (students, postdocs, junior and senior scientists in academia and industry) who study angiogenesis and those focusing on different cell types in vascular diseases, including stem cells, immune cells, neurons, tumor cells and more. Their integration within the angiogenesis community is predicted to move vascular science toward the timely translation of basic discoveries. A complimentary GRS pre-meeting will be organized by and for trainees to present their work and receive feedback from their peers and from a select panel of senior experts who will attend both the GRS and the GRC.
The GRC Chair and Vice-Chair are leaders in the field with substantial experience in organizing international scientific meetings. They are well-suited and keenly motivated to organize this meeting. The meeting will bring together a selected group of a maximum of 200 participants at Salve Regina University, Newport, RI, for a week. The venue and meeting structures are designed to foster presentations of largely unpublished data followed by extensive discussion to promote informal interactions and networking through shared meals and afternoon informal activities, especially benefitting trainees. Invited speakers are chosen based on excellence in research, relevance to the conference theme, and willingness to engage with trainees. Participants will be selected to reflect the broad demographics of scientists working in the field.
Overall, this GRC/GRS will strongly foster lasting interdisciplinary interactions and collaborations among international researchers in angiogenesis with experts in immunology, neurobiology, stem cells and cancer research. The 2025 meeting also seeks to bridge the gap between academic and industry scientists and develop the next generation of scientists at the intersection of these fields to advance our collective understanding of angiogenesis in health and disease.

Public health relevance
The 2025 Angiogenesis Gordon Research Conference (GRC) “Angiogenesis and Social Interactions with Neighboring Cells and Tissues in Health and Disease” and the accompanying Gordon Research Seminar (GRS) “Deciphering Intercellular Dialogues in Angiogenic Microenvironments” address the underlying hypothesis that angiogenesis relies on intricate crosstalk with various cell types and tissues, which influence blood vessel function. Conversely, endothelial cells secrete organotypic angiocrine factors that control and maintain tissue homeostasis, hence understanding these interactions is important for tissue regeneration and for treating diseases involving aberrant vascularization. The meeting will stimulate the generation of new knowledge by providing brainstorming opportunities for scientists of different fields (vascular, cardiac, immune, stem cell, and neurobiology) who do not often attend the same conferences and by fostering the exchange of new unpublished data and ideas, to jump-start collaborations that will move the field forward and shift paradigms.